Deep phenotypic and functional characterization of salt-responsive immune cells in human salt senstive hypertension using CTE-seq

Project Summary:
Salt-sensitive hypertension is an independent predictor of death due to cardiovascular disease
(CVD), but the mechanisms are poorly understood. Most of the research on salt-sensing
mechanisms has focused on the kidney, the vasculature and the brain; however, recent studies
from our laboratory have found that immune cells including antigen presenting cells (APCs) can
sense sodium (Na+) and contribute to salt-induced hypertension and end organ damage through
a mechanism involving increased lipid oxidation and formation of immunogenic gamma
ketoaldehydes known as isolevuglandins (IsoLGs) or isoketals. Emerging evidence suggests that
Na+ accumulates in the interstitium and activates immune cells but the specific tissue location
including the origin, antigenic site, and final target for salt-activated immune cell in cardiovascular
tissues is not known. Tools to study T cells have been rapidly expanding over the past 5 years
along with increased computing capacity including single T cells sequencing of α and β chain T
cell receptor spectra typing but very few studies have investigated APCs using these advanced
techniques and we do not know where or how they are activated and in turn activate T cells in
salt-induced CVD. We propose an innovative approach to use 5’ CITE-Seq and post hoc
sequencing, to phenotype APCs in people with salt-sensitivity of blood pressure. We will couple
the immune phenotype with IsoLG formation using our innovative approach to conjugate the anti-
IsoLG D11 ScFv antibody sequence with an oligo and use CITE-Seq to track these important
activated IsoLG-positive cells and determine if these are associated with gene expression of
sodium channels. Identifying the immune cells associated with salt-sensitivity of blood pressure
will have a far-ranging impact on our understanding of the pathogenesis of salt-induced
hypertension and other diseases aggravated by high salt consumption.

Public health relevance
Project Narrative Excess dietary salt contributes to inflammation and aggravates cardiovascular disease. A major problem with excess salt consumption is that 50% of the hypertensive and 25% of the normotensive population exhibits salt-sensitivity of blood pressure which is an independent predictor of death due to cardiovascular disease. Proposed studies will determine if immune cell activation correlates with salt-sensitivity of blood pressure and may lead to more targeted diagnosis and therapy for salt- induced hypertension.